Polarized Exocytosis: Rabs, Tethers, and SNAREs

Project Title: Polarized Exocytosis: Rabs, Tethers and SNAREs
Abstract:
The overall goal of this proposal is to understand how regulation and coordination of exocytosis
and cell polarity is achieved within the cell. Our laboratory has played a central role in
determining how Rho/Cdc42 GTPases, the exocyst, and Sro7/Tomosyn family members act in
Rab and SNARE-mediated cell surface trafficking. We were the first to suggest that exocyst
works as a highly regulated machine directing polarized trafficking and growth to specific sites at
the cell surface. In this proposal, we will delineate the mechanism by which exocyst is
allosterically regulated, model this regulation in both yeast and mammalian systems, and test the
conservation of this activation using a mouse adipocyte model of regulated exocytosis. Finally,
we will detail the role of specific phosphoinositide lipids in exocyst tethering, as well as deliver
novel structural insights into how Sro7/tomosyn family members are regulated and act as vesicle
tethers in exocytosis.

Public health relevance
Project Title: Polarized Exocytosis: Rabs, Tethers and SNAREs Project Narrative: Our investigation into the fundamental mechanisms by which cells direct polarized growth is likely to be relevant to our understanding of a diverse set of human diseases including tumor development and Type II diabetes as defects in this process have been found to be associated with a number of cancers and insulin responsiveness in humans. A molecular understanding of how these highly conserved processes are carried out by a highly conserved machinery will allow development of new approaches and novel therapeutics to combat disease.